Longitudinal Evaluation of Research Career Intentions among Students Underrepresented in Medicine

The physician-scientist workforce struggles to attract racial and ethnic groups historically underrepresented in
medicine (URiM), including individuals who are Black, Hispanic, American Indian or Alaskan Native, Native
Hawaiian, and other Pacific Islander. Because the national research agenda is often set by those conducting
scientific studies, increasing the diversity of the physician-scientist workforce has the potential to bring greater
focus on issues that disproportionately affect racial and ethnic minorities. Notably, racial and ethnic minority
physician-scientists are more likely to pursue scholarship related to racial/ethnic health inequities.
Prior work has demonstrated that research career intentions evolve significantly during medical school and that
research career intentions at graduation are associated with tangible downstream measures of research
success, including subsequent receipt of NIH funding. Our preliminary data show marked disparities between
URiM and non-URiM students in research career intentions during medical school.
We propose a 5-year, longitudinal, mixed-methods study to identify trajectories (i.e., evolution over time) of
research career intentions, and determinants thereof, in 400 URiM (based on race and ethnicity) students
matriculating into MD programs and to compare these with trajectories and determinants in 200 non-URiM
students. We will examine experiences at the individual level, such as quality of mentorship and experiences of
discrimination, as well as experiences at the institutional level, such as URiM representation in the school's
leadership. The aims are to: 1) identify trajectories of research career intentions among URiM students
throughout medical school training and make comparisons with trajectories in non-URiM students; 2) identify
student- and institutional-level predictors of research career intention trajectories in URiM students and make
comparisons with predictors in non-URiM students; 3) use qualitative methods to characterize nuanced, lived
experiences related to evolution of research career intentions. Quantitative and qualitative data will be integrated
using a convergent approach at the levels of study design, analysis, interpretation, and reporting of results.
This study is significant because it will identify potentially influential timepoints and predictors of change in
research career intention among URiM MD students that can be used to increase the racial and ethnic diversity
of the physician-scientist workforce. This diversity can help mitigate health disparities by broadening the national
research agenda and increasing research participation by underrepresented populations. Our assessment of the
roles of racism and discrimination in shaping research career intentions is innovative. The impact of our findings
will be enhanced by our strong partnerships with national organizations, including medical education leaders at
the National Academies of Sciences, Engineering, and Medicine (NASEM) and Association of American Medical
Colleges (AAMC) to disseminate our findings. This study will form the basis of a future proposal to conduct
follow-up of the cohort assembled in this study through residency and into early- and mid-career positions.

Public health relevance
The physician-scientist pipeline persistently struggles to attract and retain individuals historically underrepresented in medicine (URiM), including individuals who are Black, Hispanic, American Indian or Alaskan Native, Native Hawaiian, and other Pacific Islander. This is a 5-year, longitudinal, mixed-methods study that will identify trajectories of research career intentions, and determinants thereof, in 400 URiM students matriculating into MD programs and compare these with trajectories and determinants among 200 non-URiM students. This study is significant and innovative because it will provide granular data about the formative experiences of URiM MD students that can be used to support growth of the racial and ethnic diversity of the physician-scientist workforce.